Biological Therapeutics Product Development Subject Matter Expert Consulting Services

The NINDS has a need for biological therapeutics development subject matter expert (SME)
consultants to provide technical recommendations and advice that will support the translational
development of novel therapeutics (Biologics) for NIH drug discovery and development
programs. The support included in this contract will cover all areas of cell and gene therapies,
including chemistry, manufacturing, and controls, pharmacokinetics/pharmacodynamics,
toxicology, medical writing, bioassay development, regulatory affairs, quality assurance/quality
control, and biostatistics.